Diabetes Promotes Breast Tumor via Glycation-Induced Mechanical Changes in ECM

PROJECT SUMMARY/ABSTRACT
Diabetes mellitus is a complex disease associated with hyperglycemia. A growing body of epidemiological
evidence supports that patients with comorbidity of diabetes mellitus and breast cancer are at a greater risk of
poor prognosis and death compared with non-diabetic patients. However, the interplay between tumor
progression and diabetes is still mechanistically unclear. Hyperglycemia results in glycation within the tumor
extracellular matrix (ECM), where sugars crosslink collagen through a non-enzymatic reaction resulting in
increased matrix stiffness. Notably, ECM stiffness is correlated with metastatic and promotes malignancy of
tumors through multiple aspects, such as promoting proliferation and epithelial-mesenchymal transition (EMT).
ECM stiffness also regulates endothelial cells, as our lab has shown previously that ECM stiffness promotes
tumor angiogenesis and damages vascular integrity. Malformed and hyper-permeable vasculature is a hallmark
of breast tumors and is known to lead to more metastasis and a more aggressive tumor phenotype. Noting the
carcinogenic effect of glycation and the association between diabetes and tumor progression, my study aims to
understand the mechanism by which diabetic hyperglycemia promotes breast tumor progression via glycation-
mediated matrix stiffening. I have recently established a murine model where hyperglycemia was induced prior
to tumorigenesis. With this model, I find that hyperglycemia increases tumor growth, tumor stiffness, advanced
glycation end-product (AGEs) concentration, and EMT of tumor cells. Upon treating diabetic mice with glycation
inhibitors, I observed a reduction of the previously tested metrics in diabetic tumors to levels comparable with
non-diabetic tumors. These findings describe a novel mechanism by which diabetic hyperglycemia promotes
breast tumor progression and provide evidence that glycation inhibition is a potential adjuvant therapy for diabetic
cancer patients due to its key role of matrix stiffening in both diseases. In the F99 phase of this application, these
findings will be extended by determining the mechanisms by which glycation-mediated ECM stiffening activates
tumor angiogenesis (Aim 1). Noting that glycation stiffens ECM and produces AGEs which initiate cell signaling
through RAGE receptors. AGE-RAGE signaling has been implicated in angiogenic behavior. A particular
emphasis will thus be to tease apart the effect of AGE-RAGE signaling and matrix stiffening on tumor
angiogenesis. Macrophage-involved chronic inflammation is emerging as a link between diabetes and breast
cancer. My preliminary data show that there are more M2 macrophages within stiffer tumors. Thus, in the K00
phase (Aim 2), a research/training environment will be sought to examine the mechanism by how glycation-
mediated ECM stiffening promotes tumor progression via increasing tumor immune cell infiltration and
influencing immune cell behaviors. The ultimate goal of my studies will be to provide a more holistic
understanding of how diabetic hyperglycemia influences tumor progression and to serve as a basis for future
therapeutic intervention.

Public health relevance
PROJECT NARRATIVE Patients with comorbidity of diabetes mellitus and breast cancer have been shown to be at a greater risk of poor prognosis and death than non-diabetic patients. However, the interplay between tumor progression and diabetes is still mechanistically unclear. Noting that glycation stiffens tumor ECM and ECM stiffening promotes tumor progression, here, I will investigate the mechanism by which diabetic hyperglycemia-mediated glycation promotes breast tumor progression via ECM stiffening to uncover potential adjuvant therapy for diabetic cancer patients.